Data Core

Project Summary: Data Science Core
Our team for this BRAIN Initiative proposal on Oxytocin Modulation of Neural Circuit Function and Behavior is
located at NYU School of Medicine, and staff for the Data Science Core are located in the NYU Health Sciences
Library and Division of Biostatistics. This proximity facilitates their interactions, already leading to a number of
collaborations and efforts to promote data sharing, standardization, and archiving that form a solid foundation
for this proposed Data Science Core. The Core Director is Dr. Alisa Surkis, a computational neuroscientist and
data archivist, together with other Core staff members Mr. Kevin Read (an informationist) and Dr. Andrea Troxel,
head of Biostatistics at NYU School of Medicine.
This Data Science Core will help ensure the management and stewardship of the datasets to be collected
in our Projects and by the other Cores, including behavioral data (short episodes and weeks-long movies),
physiological recordings (in vivo and in vitro, whole-cell and extracellular recordings), imaging (2-photon,
confocal, and fiber photometry), and gene expression profiling. Aim 1 of the Data Science Core is to standardize
data collection formats across Project team labs, in formats adopted from consortium sites such as Neurodata
Without Borders and CRCNS. Aim 2 is to archive these data for perpetuity, ensuring an enduring lifetime of raw
data, annotations, and analyses, in formats amenable to easy sharing between investigators. Aim 3 is to
coordinate and communicate with other investigators and BRAIN Initiative teams, including other Data Science
Cores for consensus building and sharing techniques for troubleshooting. In Aim 5 we will provide rigorous
training and practices in statistical analysis, incorporating faculty from the division of biostatistics at NYU into the
Data Science Core.